Notch Signaling during Organ of Corti Maturation and Maintenance

The majority of deafness and vestibular disorders occur due to loss or dysfunction of critical cells in the inner
ear, including hair cells, supporting cells and neurons. Once lost or impaired, these cell types show little or no
ability to regenerate in the mammalian inner ear. In recent years, there have been a number of exciting results
regarding approaches to generate new hair cells in the endogenous epithelium, often through transformation of
existing supporting cells. The Notch signaling pathway has been shown to be a key pathway in regulating the
determination of the hair cell or supporting cell fate, through a process called lateral inhibition. In this system,
cells expressing the Notch ligand activate Notch in the surrounding cells and prevent them from adopting a hair
cell fate. This signaling creates the sensory mosaic in which each hair cell is surrounded by supporting cells.
Inhibition of Notch can promote the conversion of supporting cells into hair cells, providing an avenue for
replacing lost or dysfunctional hair cells. However, Notch signaling is a powerful pathway that often plays
multiple roles during development. Our preliminary results indicate that in addition to cell fate choices, Notch
also plays an essential role in cochlear maturation or maintenance via the JAG1 ligand. Specifically, our
results demonstrate that JAG1 deletion does not cause cell fate alterations but instead leads to hearing deficits
resembling auditory neuropathy in humans. We hypothesize that activation of Notch via the JAG1 ligand is
required for aspects of sensory maturation and/or maintenance in the cochlea. The proposal outlined here
aims to test this hypothesis, by (1) establishing the effects of deletion of Jag1 in the cochlear epithelium, (2)
identifying the cell type and receptors that mediate JAG1 effects, and (3) establishing direct and indirect targets
for JAG1-Notch1 signaling. Understanding the role of Notch signaling in postnatal maturation and sensory
maintenance is essential for future regenerative therapies that rely on manipulating Notch signaling for hair cell
replacement.
.

Public health relevance
For the cochlea to function properly in the adult, multiple cell types must mature properly into specific cell types, including hair cells, supporting cells and neurons. This proposal seeks to define the molecular signaling pathways necessary for the final steps of cell maturation in the cochlea, steps that are currently not well understood. Deciphering these processes is critical for understanding hearing loss and for developing therapeutic interventions.